Mechanisms and functions of RPL3L ribosomes

RPL3L, or ribosomal protein L3-like, is a highly conserved, vertebrate-specific duplicated paralog of the
ubiquitous ribosomal protein L3 (RPL3). While most ribosomal protein gene duplications are silent pseudogenes,
RPL3L is highly and exclusively expressed in adult striated muscle and is the predominant form in cardiac (~95%)
and skeletal (~60%) muscle. Such a tissue-specific paralog switching is intriguing especially given that striated
muscle comprise ~50% of body weight and 50-75% of all body protein, and that RPL3 is one of the most
important ribosomal proteins: it is the closest protein to ribosome catalytic center, functions as a gatekeeper to
the decoding center, and is required for the first step of 60S subunit assembly. Furthermore, the development-
and tissue-specific RPL3-to-RPL3L switch is reversed during muscle growth when the demand for protein
synthesis is high. We and others recently reported bi-allelic heterozygous missense mutations in RPL3L co-
segregating with severe neonatal dilated cardiomyopathy and fatal heart failure in five unrelated families. Despite
the evolutionary, physiological and pathological significance, it remains unclear why the genetic code in half of
human body mass is interpreted by ribosomes differ by a key component, i.e., RPL3 vs. RPL3L, in a highly
regulated manner. The mechanistic details of whether and how RPL3L ribosomes function differently from
ubiquitous RPL3 ribosomes remains poorly understood, due in part to the lack of in vitro and in vivo systems
where the relative expression of RPL3 and RPL3L are perturbed. To address this barrier, we have generated
human cell lines and mouse models predominantly expressing either RPL3 or RPL3L in cardiomyocytes. Our
preliminary results support a model that RPL3L ribosomes promote protein homeostasis in striated muscle cells.
We will use a combination of biochemical, imaging, genomics, and computational approaches to test our
hypothesis. By answering the long-standing question of why the heart needs a special ribosome, our study will
reveal how heart functions at the molecular and cellular level and establish a new paradigm for how ribosomes
specialize in tissues. From the disease perspective, our study may shed lights on the pathogenesis of dilated
cardiomyopathy and lay the foundation for the development of new therapies.

Public health relevance
The genetic code in heart and skeletal muscle are decoded by a unique molecular machine that is different from the rest of the body, mutations of which causes fatal heart failure in infants. The proposed studies investigate the mechanisms allowing specialized protein synthesis in the heart. Completion of this project will shed lights how heart works at the molecular level and lay the foundation for the development of new therapies for heart diseases.